Post-Doctoral Research Training in Genetic Epidemiology

Description (provided by applicant): The primary objective of this revised post-doctoral research training program is to produce cutting edge independent scientists and future research leaders in genetic epidemiology. We are proposing to do this in a multidisciplinary setting and with emphasis on substantive applied orientation in cardiovascular disease (CVD) and CVD risk factors and other complex traits related to heart, lung, and blood disorders. We believe that the research environment at Washington University is outstanding for carrying out research in genetic epidemiology and cardiovascular genetic epidemiology. The cornerstone of this new program is its emphasis on intense and sustained individualized training of each trainee under the supervision of an experienced preceptor. Indeed, emphasis on individualized training is one of its hallmarks. Its centerpiece is an Individualized Training Pathway (ITP) developed for each trainee by the Program Director, the trainee's preceptor(s), and the trainee. An individual trainee's ITP will reflect his/her educational background, the previous research experience if any, the particular research interests of the trainee, and will address the curriculum needs as well as the type of research experience he/she needs. The focus of the research and training philosophy advocated by the Program Director and the participating preceptors is a clear understanding of the concepts, principles, and methods of genetic epidemiology necessary for investigating the physiological and pathophysiological processes that underlie CVD and related complex traits. We are requesting funds for 2 slots in the first year, 3 in the second, and 4 thereafter. Our proposal rises to the challenge by blending and integrating carefully chosen didactic training with greater emphasis on a direct hands-on research and grant writing experience. One of the great strengths of this training program is that the vast established resources and rich interdisciplinary training environment of the entire DBBS, as well as that of the GEMS masters degree training program in genetic epidemiology are available to all post-doctoral trainees in this program. The proposed post-doctoral research training program aspires to produce future genetic epidemiologists in much demand in the current market place for pursuing cardiovascular and other biomedical research. The research training environment at Washington University is outstanding, which also has a separate Office of Post Graduate Affairs to look after postdoctoral trainees and their special needs.